Effects of Health Shocks at Older Age on Older Adults and their Families: New Evidence from Large-Scale Administrative Data

PROJECT SUMMARY
Family plays a central role in shaping the experiences of aging. Any health shock not only affects the patient
but also reverberates throughout the family unit, taking a physical, emotional, and financial toll on family
members. The effect on families is likely to be particularly pronounced for health shocks that lead to a
pronounced decline in independence, as, for example, happens with the progression of Alzheimer’s Disease
and Related Dementias (ADRD). The ways families manage sharp changes in health can have profound
effects on both the patient’s well-being and that of their caregivers.
Despite the intricate relationship between family dynamics and health outcomes at older ages, public policies
and much of the existing research in the U.S. have predominantly focused on individual patients rather than
the broader family context. The dearth of evidence relates not to the lack of interest, but to the absence of
datasets that could allow studying the effects of health shocks on families. In this project, we propose to start
closing this gap in knowledge by leveraging the new extensive Census Bureau infrastructure for linking United
States survey and administrative data.
We will construct and analyze a novel individual-level database that links the health trajectories of older adults
to the physical, mental, and economic well-being of their family members across multiple generations, covering
twenty-five years from 1999 to 2024. Using this new database, we will comprehensively examine the
interdependencies between the mental, physical, and economic well-being of older adults and their families in
the United States. First, we will describe the variation in family circumstances of older adults at the time of
different health shocks. We will consider variation across demographic groups, local geographies, and socio-
economic circumstances. Second, we will use econometric techniques for causal inference to quantify how
much major health shocks affect the health and economic well-being of family members, including spouses
and adult children.

Public health relevance
PROJECT NARRATIVE Family plays a central role in shaping the experiences of aging - a health shock not only affects the patient but also reverberates throughout the family unit, taking a physical, emotional, and financial toll on family members; this is particularly pronounced for health shocks that lead to a decline in independence, as occurs with the progression of Alzheimer’s Disease and Related Dementias (ADRD). The ways in which families manage such health shocks can have profound effects on both the patient’s well-being and that of their caregivers. In this project, we will construct a new database that links the health trajectories of older adults to data on the physical, mental, and economic well-being of their family members across multiple generations; we will use these data to document how health shocks at older age affect families in the United States.